HIV Reservoir Dynamics Associated with Metabolic Complications of HIV Infection

With continuous antiretroviral therapy (ART) and viral suppression, life expectancy for people with HIV (PWH)
is approaching that of people without HIV. Some estimates suggest the mortality gap is 10 years or less, when
comparing persons with and without HIV. However, with prolonged survival there have also been increases in
non-AIDS defining age-related comorbid diseases. What has now emerged in contemporary HIV clinical care is
a convergence of declining mortality with effective ART treatment, combined with the earlier onset of age-
related comorbidities. This means a growing portion of the lifespan for PWH involves morbidity and disability
from multiple diseases like obesity, diabetes, hepatic steatosis, cardiovascular diseases, and cancer. Several
of these comorbidities are related to changes in metabolism, however the mechanism of these changes is not
understood but may be unique to HIV. One common link between HIV and these metabolic diseases is that
both are associated with chronic immune activation (IA). For example, people who are obese without HIV have
elevated levels of circulating pro-inflammatory cytokines such as IL-6 and TNF. The same is true in treated HIV
infection. There are several potential causes of IA including an altered microbiome, microbial translocation, and
other infections like cytomegalovirus (CMV). However, we and others have shown that HIV RNA+ cells persist
in lymphatic tissues despite fully suppressive ART, and we think this is a significant contributing cause of IA in
PWH. Our primary hypothesis is that the size of this dynamic reservoir of HIV RNA+ cells is a primary driver of
IA which, in turn, leads to development of these metabolic comorbidities. We will test this hypothesis in 2 ways.
We will first explore the natural history of metabolic dysfunction in HIV using a large tissue repository of gut
and lymph nodes (LN) we have collected over the last 20 years in multiple studies. We will measure the size of
the HIV reservoir in gut and LN and frequency of hormone producing cells (e.g., GLP-1, PYY, GIP) in HIV
negative people and PWH before and during ART and when viral recrudescence with treatment interruption.
We will measure markers of IA and microbial translocation in mononuclear cells from those tissues as well as
plasma that was collected at the time of the biopsy. Collectively, these data will provide insight into how
metabolism is altered in HIV infection and the relationship to the size of the HIV viral reservoir. Our second
approach is to focus on obesity as one of the most common comorbidities in PWH. We will enroll PWH with
and without obesity (BMI30) and HIV-negative people with and without obesity into an 18-month prospective
observational study. We will collect LNs, ileal, and colonic samples as well as PBMC and plasma at the
baseline and 18-month timepoint. We will collect functional metabolic data with DXA and MRI scans to
measure fat distribution throughout the body and we will do extensive metabolomics and functional genomics
on these same tissues. We will apply machine learning algorithms to this extensive data set to determine the
relationship of viral reservoirs to development of obesity as well as other predictors of obesity.

Public health relevance
Project Narrative Treated HIV infection is associated with early development of comorbidities such as obesity, diabetes, and liver steatosis, which are associated with aging. Our hypothesis is that HIV reservoirs in lymph nodes and gut are primary contributors to the development of these comorbidities by causing chronic immune activation. We will test this hypothesis through exploration of gut, lymph node, and blood from our extensive tissue bank and with a longitudinal observational study of these same tissues from people living with HIV with and without obesity and HIV-negative people with and without obesity.